Promoting community-based Kangaroo Care among mothers of low birth weight infants in rural India

SUMMARY. The primary objective of this K23 award is to provide Dr. Nisha Fahey, DO, MSc, Assistant Professor
in the Department of Pediatrics at the UMass Chan Medical School, with the research training, mentorship, and
protected time necessary to accelerate her career as an independent physician-scientist committed to
improving the health of mother-infant dyads. As a primary care pediatrician with global health fellowship
training, Dr. Fahey is committed to reducing infant mortality among low birth weight infants, particularly in global
settings. Her K23 research will focus on promoting the practice of Kangaroo Care, featuring skin-to-skin care,
among mothers of low birth weight infants in rural India. Despite the lifesaving benefits of this low-cost
therapy, community-based Kangaroo Care for low birth weight infants discharged from the Neonatal
Intensive Care Unit (NICU) remains a crucial gap in research to prevent neonatal mortality.
This proposal seeks to develop a multicomponent intervention that promotes the practice of
Kangaroo Care after NICU discharge among mothers of low birth weight infants in rural India. The effects
of poverty and adverse social circumstances further increase their risk of mortality. To achieve this goal, Dr.
Fahey seeks to develop expertise in specific methodology and content areas including community-engaged
research, implementation science, and trial design, including multiphase optimization strategy (MOST) design,
in global settings. If granted this K23 award, Dr. Fahey will use these methods to perform a MOST design-based
trial centered on the premise that the continuation of Kangaroo Care after NICU discharge among the mothers
of low birth weight infants in rural Indian communities requires: 1) engaging communities to refine and pilot test
community-informed interventions (Aims 1 and 2) and 2) developing an optimized, multicomponent intervention
that balances impact and resources (Aim 3). Dr. Fahey leads a ten-year institutional collaboration between
Bhaikaka University and UMass Chan Medical School focused on capacity-building research and community
health in rural India, which ideally positions her to perform this proposed study. By the conclusion of this
award, Dr. Fahey’s research and training plan will yield a community-informed, optimized,
multicomponent intervention and the skillset to conduct an effectiveness trial in an R01 (PAR-22-105).
Dr. Fahey has a well-established team of mentors with clinical and research expertise along with the
track record and commitment needed to successfully support her in establishing a federally funded independent
program of research to enhance maternal and infant health in global settings. After thoughtful review of the
critiques received, Dr. Fahey and her mentorship team have carefully crafted a training plan that builds on
existing strengths and addresses current gaps. This K23 award will build on existing international
community partnerships and equip Dr. Fahey with the skills to advance her emerging program of
research to focus on intervention development and evaluation in global settings.

Public health relevance
PROJECT NARRATIVE Kangaroo Care is a low-cost, lifesaving intervention featuring skin-to-skin contact between mother and infant that is underutilized in the community setting in rural India among low birth weight infants after discharge home from the Neonatal Intensive Care Unit. Community-engaged approaches are needed to culturally adapt interventions to overcome barriers to community-based Kangaroo Care. Pairing community engagement and implementation science with a multiphase optimization strategy (MOST) design-based trial will yield a community-informed, multicomponent intervention that balances effect and pragmatics in resource-limited, settings.